Data management

Data Management Core
SUMMARY
The Data Management Core aims to provide comprehensive data management and statistical support for the
ICEMR program, establishing a centralized data management system for laboratory and field activities to collect
and archive data and specimens from all study sites. It will collaborate with investigators and field leaders on
study design, protocol development, training, and biostatistical analyses while maintaining rigorous standard
operating procedures and data quality assurance processes to ensure uniformity, timely reporting, and secure
data and specimen archiving. The Core has been critical to the success of the existing Southeast Asia ICEMR
program, and this proposal will leverage shared resources and qualified personnel to reduce costs and increase
efficiency. Benefiting from the ongoing ICEMR, our investigators have established data management SOPs. The
proposed ICEMR Data Management Systems (DMS) will be based on these SOPs, with additional hardware
and software acquisition. It will integrate with the existing infrastructure of partner institutions, maximizing the
scientific potential of data and proliferating the FAIR-sharing principle throughout the malaria research
community. The specific aims are: (1) developing a centralized and standardized data acquisition and
management system through an electronic data capture framework for all ICEMR activities; (2) providing
biostatistical support and training for conducting rigorous biostatistical analyses that address research questions
across projects.